Training Program in Reproductive, Perinatal and Pediatric Epidemiology

ABSTRACT
The pathway from conception to adulthood is influenced by many factors including genetics, social factors,
nutrition, infection and inflammation and the environment. The impact of these factors depends on the type and
timing of exposures, relative to critical windows of vulnerability. Experimental science focused on
understanding, measuring, and intervening on factors that influence reproductive and pediatric health is
especially challenging due to the innate vulnerability of these populations. Epidemiology provides a rigorous
methodological framework to interrogate important questions about reproductive, perinatal, and pediatric health
and disease. Epidemiologists are trained to estimate the prevalence of reproductive and pediatric conditions,
causal relationships between a range of exposures and outcomes, and the role social determinants play in
creating health disparities. Epidemiologic methods are also valuable for evaluating the implementation of
interventions to improve reproductive and pediatric health outcomes. Rigorous methods tailor study design to
maximize data quality and carefully construct analyses to minimize bias and emphasize interpretation. Our
Reproductive, Perinatal, and Pediatric Epidemiology Predoctoral Training Program prepares the next
generation of epidemiologists to investigate the real world contextual and interacting influences of genetics,
physical environment, and social environment that impact reproductive, perinatal, and pediatric health. Training
comprises didactic training and mentored research, complemented with professional development and
enrichment opportunities. Primary and Affiliate Preceptors have extensive research portfolios and a range of
expertise to offer. Trainees gain appreciation for the biological underpinnings of reproductive and pediatric
health. They learn to identify longstanding and emerging problems and apply rigorous research methods in
complex, real-world settings to study them. Trainees complete our program with a sophisticated
methodological toolbox, experience integrating methods with substantive area knowledge, and requisite
professional skills to engage in collaborative science that advances the field and tackles important research
questions that impact reproductive and child health.

Public health relevance
PROJECT NARRATIVE UNC's Reproductive, Perinatal, and Pediatric Epidemiology Predoctoral Training Program prepares the next generation of epidemiologists to investigate the real world problems in reproductive, perinatal, and pediatric health.